A rapid method for global and targeted miRNA next generation sequencing

PROJECT SUMMARY
MicroRNAs (miRNAs) are small non-coding RNAs (15-25 nt) that play a pivotal role in the regulation of protein
synthesis by modulating mRNA translation. miRNA expression, localization and secretion are closely
modulated in response to biological stimuli. These processes are often dysregulated in cancer resulting in
miRNA expression profiles that are unique to cancer type and stage. Apart from its utility in early cancer
detection, tumor miRNA profiling has been shown to improve patient survival when used in treatment response
monitoring. Recent liquid biopsy studies have demonstrated the utility of miRNAs as circulating biomarkers for
early cancer diagnosis and for monitoring disease progression and treatment response. However, existing
assays are not sensitive to the subtle changes in miRNA profiles and require prior knowledge of the
dysfunctional miRNAs. While next-generation sequencing (NGS) can be used for agnostic miRNA profiling,
there is a clear lack of a rapid, easily administrable NGS-based molecular diagnostic assay that efficiently
captures subtle changes in microRNA profiles during disease progression owing to the small size and scarcity
of miRNA in biological samples, particularly in biological fluids. In this application we propose to develop a
novel approach called miREALLY that directly converts miRNA to sequence-ready libraries in just two steps –
direct ligation of ClaretBio's proprietary adapters to miRNA, followed by a step that performs reverse-
transcription and library-amplification in a single reaction. The proof of concept work described here will identify
the ideal combination of reagents and enzymes that facilitate efficient library conversion, with metrics that
outperform current small-RNAseq methodologies. In Aim 2 we will further optimize the protocol and determine
the limit of detection and input range to expand the utility of the approach with biological samples using non-
small cell lung cancer as a model. Finally in Aim 3 we will leverage the unique design of the adapters for
targeted enrichment of miRNA – by designing splint adapters with sequence complementarity to the ends of a
specific miRNA from complex miRNA mixtures. This allows capture of a panel of known miRNA and their
variants in a single workflow, eliminating the need for additional targeted enrichment steps. Accomplishing the
aims described here would result in a robust miRNA NGS assay that not only enables global miRNA profiling
but also helps monitor changes to levels of specific miRNA biomarkers and their variants thereby improving our
understanding of intracellular and circulating miRNA biology and facilitating more precise disease diagnosis
and monitoring in the clinical setting.

Public health relevance
PROJECT NARRATIVE The project aims to develop a robust, molecular profiling tool and a target-enrichment assay for early detection and monitoring of cancer using microRNAs (miRNA), a group of vital small RNA molecules. Claret Bioscience will develop a novel method specifically for miRNA based on a proprietary technology that efficiently generates sequencing libraries from minimally abundant, short, nucleic acids fragments. The resultant next-generation sequencing assay will enable more precise cancer diagnosis by accurately measuring changes in composition and abundance of miRNA in tumor and liquid biopsies and enable novel biomarker discovery and evaluation of newly designed miRNA therapeutics.